NEWARK AIDS COMMUNITY OUTREACH DEMONSTRATION PROJECT

The Newark AIDS Community Outreach Project is a demonstration of outreach, education/prevention, risk-reduction, and other programs and initiatives towards reduction of the spread of AIDS among intravenous drug abusers (IVDAs), spouses and sexual partners. The project, has identified six objectives to meet such demonstration. These objectives include efforts to: 1. Increase outreach to IVDAs and particularly the IVDA's female spouse, and or sexual partner 2. Integrate State and City administered services delivery, networking, and referral policies and procedures 3. Increase IVDA incentives to participate in risk reduction activities and behaviors 4. Increase drug abuse treatment capacity to provide AIDS health education/counselor services to IVDAs in treatment, including spouse, family members, and/or sexual partners 5. Increase community-based organizations' participation, and capacity to outreach to and serve the IVDA and related at-risk populations. 6. Enhance existing referral mechanisms to assist the IVDA, spouse, family member, and/or sexual partner in securing needed testing, counseling, medical, and support services. Achievement of these objectives is proposed through the establishment of a community or oganization administrative structure, which will be integrated with the existing Robert Wood Johnson AIDS Health Services Project, and the pilot and demonstration projects currently funded within Newark through grants from the CDC. The focus of this Project includes sub- contracting for the placement of Health Educator/counselor services within existing Family Planning, Maternal and Child Health, STD, drug abuse treatment and other community-based agencies within the City of Newark. Additional proposed efforts include: (1) the expansion of the existing Coupon Program which provides free detoxification, and AIDS education (including pre and post testing) to "street" IVDA, upon coupon redemption at a participating Drug Abuse treatment program; (2) sub-contracting with the City of Newark for the establishment of a City AIDS liaison, and (3) sub-contracting with Renaissance House to provide medical van outreach services to the IVDA and related at-risk populations with high-risk areas of Newark.